Investigating the role of HSC70 AMPylation on nuclear localization and chaperone function

Project Summary
Coronary heart disease, also called Ischemic Heart Disease (IHD), is the leading cause of death worldwide.
Repeated episodes of cardiac stress in IHD patients leads to an increase in misfolded proteins in their hearts. In
response to this acute onset of cellular stress, heat shock proteins (HSP)s are upregulated in myocardiocytes
and help restore protein homeostasis (proteostasis). Heat shock cognate 71 kDa (HSC70) is an essential,
HSP70 chaperone that is located in the cytosol in the absence of cellular stress. This ATP-dependent chaperone
actively refolds, degrades, and disaggregates proteins. HSC70 is also critical for autophagy, a cellular
recycling/degradation process that protects the heart from misfolded proteins following ischemia. Impaired
HSC70 function has been implicated in heart disease, yet despite the critical role of HSC70 in cellular physiology,
the molecular mechanisms that regulate nuclear transport and govern the disparate functions of HSC70 remain
unknown.
Protein AMPylation recently emerged as a distinct PTM that regulates HSP70 family chaperones through the
addition of adenosine monophosphate (AMP) to threonine residues. This process is catalyzed by the mammalian
AMPylase, HYPE. My preliminary work revealed that HYPE AMPylates HSC70 on two sites, and increased
cellular AMPylation levels prevent the nuclear-cytosolic shuttling of HSC70 as well as its ATPase activity. I also
found that, similar to decreased levels of the HSC70 ortholog HSP-1, increased AMPylation inhibits
autophagosome formation in C. elegans. These data suggest that HYPE-mediated AMPylation of HSC70 inhibits
its critical functions associated with maintaining proteostasis, including nuclear-cytosolic shuttling, protein
folding, and autophagy.
The goals of this proposal are to 1) define the functional impact of HYPE-mediated AMPylation on HSC70 and
2) determine the impact of AMPylation on HSC70’s nuclear-cytosolic shuttling mechanism. Ultimately, we aim to
define how a novel post-translational modification (PTM), AMPylation, regulates HSC70 function in proteostasis
and cardiovascular diseases. Advancing our knowledge of the mechanisms that control HSC70 function is critical
to identify novel avenues to therapeutic strategies that capitalize on restoring HSC70 regulation.

Public health relevance
Project Narrative Recent studies have shown that in some heart diseases, Heat Shock Cognate 70 (HSC70) loses its ability to translocate to the nucleus under stress, causing an accumulation of misfolded proteins in the heart, but it is unknown why. Despite HSC70 being an essential chaperone with many functions in our cells’ protein quality control systems, there remains a lack of knowledge surrounding the mechanisms and regulation of HSC70 in heart disease. This proposal will utilize in vitro and cellular cardiomyocyte models to interrogate how AMPylation, a novel post-translational modification that regulates other heat shock 70 chaperones, is impacting 1) HSC70 mechanistic chaperone functions, including protein folding and degradation capabilities, and 2) HSC70 nuclear translocation in cardiomyocytes with altered AMPylation levels.